The Mountain West Arthritis Secondary Prevention Program

PROJECT SUMMARY
Osteoarthritis (OA) impacts about 1 in 4 adults in the U.S and is responsible for considering costs and loss of
quality of life for impacted individuals. The prevalence and adverse impacts of OA are greater for persons from
racial/ethnic minoritized groups, with lower income and/or living in rural communities. Secondary prevention of
arthritis-attributable activity limitations is a critical goal for persons with OA. Arthritis-appropriate evidence-
based interventions (AAEBIs) are available. A core component of AAEBIs is physical activity, which is often
decreased for persons with OA. Available AAEBIs include counseling from a healthcare provider about physical
activity, and CDC-endorsed programs to increase physical activity and promote self-management. Despite the
potential benefits, uptake of AAEBIs is low, particularly in communities that experience disparities.
The Mountain West Arthritis Secondary Prevention Program (MW-ASP) is special interest project situated in the
Mountain-West Prevention Research Center (MW-PRC). The MW-PRC seeks to increase the reach of EBIs to
persons in communities experiencing disparities and to disseminate, scale and sustain strategies and tools to
community, public health and academic audiences. The MW-ASP aligns with these goals and will work with the
MW-PRC to connect persons with OA to physical activity counseling and community-based AAEBIs. We will
conduct a hybrid type 3 effectiveness-implementation trial using sequential, multiple assignment, randomization
to evaluate 1) two text messaging (TM) strategies to reach persons with OA and enroll them in physical activity
counseling provided by physical therapists; and 2) two strategies to engage enrolled persons in the Walk with
Ease (WWE) AAEBI for sustained self-management. Persons with OA receiving care in clinics partnering with
the MW-PRC will be identified via a population health management strategy through the electronic health record
and randomized to; 1) TM outreach, or 2) TM outreach + motivational messages to enroll in activity counseling.
Enrolled persons are then randomly assigned to activity counseling and information to engage in WWE delivered
with one of two formats promoted by the Arthritis Foundation; 1) self-directed; or 2) enhanced self-directed. The
trial has 3 Aims; 1) Determine differences in reach between two TM strategies to enroll persons with OA in
activity counseling (primary outcome), 2) Determine differences in reach between two strategies to engage
enrolled persons in the WWE AAEBI (secondary outcomes), and 3) Examine outcomes across additional RE-
AIM domains (effectiveness, adoption, implementation, maintenance). The findings from the MW-ASP will
produce generalizable tools to increase the reach of effective interventions for persons with OA.

Public health relevance
PROJECT NARRATIVE The Mountain West Arthritis Secondary Prevention Program will to investigate scalable strategies to improve the reach of evidence-based interventions for persons with osteoarthritis who in rural, low income and ethnically diverse communities. The research in this proposal will result in generalizable translational tools and scalable strategies that can benefit other communities, health systems and persons with arthritis.